POSTMORTEM BRAIN TISSUE EXAMINATION IN NEUROPSYCHIATRIC DISORDERS

Postmortem studies in neuropsychiatric disorders test hypotheses with regard to schizophrenia, suicide, addictions and normals. Using autoradiography we found the following in brains of drug free schizophrenics: (1) increased AMPA (glutamate) binding in caudate nucleus; (2) decreased neurotensin binding in entorhinal cortex (ERC), (layer 2); (3) increased D2/D3 binding in ERC (layers 2,5 and 6); (4) decreased 5HT-2 binding in layers 3/4 of dorsolateral prefrontal cortex (DLPFC); and (5) decreased 5HT reuptake in DLPFC. Using in situ hybridization we found decreased mRNA for cholecystokinin in subiculum and ERC in schizophrenics.